Biobehavioral Efficacy of the Semi-Elevated Side-Lying Position for Feeding Preterm Infants

Project Summary/Abstract
Preterm infants (≤ 37 weeks gestational age at birth) only represent 10% of live births in the United States, yet
account for 43% of the total cost of infant care in hospitals. Delays in the development of oral feeding skills in
preterm infants are one of the main reasons for prolonged hospitalization, which increases the cost of care and
delays unification with family. Preterm infants often experience oral feeding difficulties due to immaturity of their
neurologic, cardiorespiratory, gastrointestinal, and oral-motor systems. Recurrent distress during feeding alters
sensory-motor pathways in the developing brain, leading to long-term, maladapted feeding behaviors. Up to 41%
of preterm infants experience feeding difficulties that continue into childhood, which has implications for long-
term growth and neurodevelopment. Traditionally, the semi-elevated supine position (hereafter referred to as
supine position) has been used in neonatal intensive care units when preterm infants are bottle-fed. Over the
past decade, the semi-elevated side-lying position (hereafter referred to as side-lying position) has been
proposed as a potential strategy to improve preterm infants’ oral feeding skills and to reduce adverse events
during feeding, but the quality of the evidence to support the side-lying position as a feeding intervention is in an
early, emergent stage. Due to limited evidence, clinicians are inconsistent in their use of the side-lying position,
exposing infants already experiencing feeding challenges to unpredictable and variable feeding positions, which
can further complicate their feeding skill development. Additional research is necessary to provide more definitive
knowledge on whether the side-lying position improves preterm infants’ feeding skills and to generate needed
information to enhance precision to the application of this intervention. To address this gap, we propose a single-
center randomized cross-over trial to gain a thorough understanding of the biobehavioral efficacy of the side-
lying vs. the supine position on physiologic and behavioral responses of preterm infants while transitioning from
tube to full oral feeding, and to identify infant characteristics associated with the intervention response. The
specific aims are to: 1) compare physiologic responses in preterm infants while bottle feeding in the side-lying
vs. supine position; 2) compare behavioral responses in preterm infants while bottle feeding in the side-lying vs.
supine position; and 3) identify moderators of intervention response, evaluating infant sex, maturity level, and
co-morbid conditions. Physiologic responses will include continuous measures of heart rate, respiratory rate,
oxygen saturation, and autonomic nervous system regulation (heart rate variability and splanchnic-cerebral
oxygen ratio) prior to, during and after feeding. Behavioral responses will include observations of the infant’s
feeding behavior through microanalysis of the sucking and breathing waveform data and videotaped feedings
(Suck-breathe coordination and Early Feeding Skills assessment tool). Data will be analyzed using a linear mixed
effects model. The results of this study will provide vital knowledge to guide evidence-based practices that
support and enhance oral feeding in preterm infants while also providing needed data for a pivotal efficacy trial.

Public health relevance
Project Narrative Preterm infants commonly have problems with oral feeding, which contributes to their negative health and development, resulting in prolonged hospital stays, increased health care costs, and delayed reunification with their families. The goal of this project is to examine the efficacy of an intervention strategy that has the potential to significantly improve oral feeding skills of preterm infants and to prevent adverse events during feeding while infants are learning how to feed orally. This project is highly relevant to public health because it will provide vital knowledge to guide evidence-based practices that support and enhance oral feeding skills and development in preterm infants.